Developing Effective Approaches to Extend Hematopoietic Healthspan by Targeting Cell-Extrinsic and Cell-Intrinsic Alterations at Middle Age

PROJECT SUMMARY/ABSTRACT
Aging is associated with functional decline of the hematopoietic system and clonal hematopoiesis (CH), a
poorly understood process by which long-lived hematopoietic stem cells (HSCs) and their progeny with certain
somatic mutations undergo positive selection. Individuals with CH have increased risk of developing blood
cancer, cardiovascular disease, type 2 diabetes, and all-cause mortality. Thus, CH is a healthspan-limiting
condition. Understanding how and why CH occurs with aging, and defining effective interventions to extend
healthspan, have strong potential to reduce the frequency or severity of CH-associated diseases in aged
individuals. Our laboratory has recently made formative discoveries that the aging bone marrow
microenvironment and impaired HSC mitochondrial function cooperate to cause HSC aging. These
discoveries have inspired us to define the components of aging that contribute to positive selection of CH-
mutant HSCs. The major goal of this proposal is to determine processes by which hematopoietic-intrinsic and
-extrinsic factors cause age-associated CH. Using a mouse model of a common CH mutation in DNMT3A, our
preliminary data demonstrate that both hematopoietic-intrinsic and -extrinsic adaptive mechanisms facilitate
selective advantage of Dnmt3a-mutant HSCs in the context of aging. We hypothesize that Dnmt3a-mutant
HSCs are adapted to survive and self-renew in an aging microenvironment through enhanced mitochondrial
metabolism, and that they promote premature senescence of the microenvironment to further their selective
advantage. In Aim 1, we will identify the specific mitochondrial alterations in Dnmt3a-mutant HSCs that
functionally increase their competitive advantage in an aging microenvironment. In Aim 2, we will determine
the mechanisms by which Dnmt3a-mutant HSCs induce senescence of mesenchymal stromal cells in the BM
microenvironment. In Aim 3, we will determine the extent to which targeting mesenchymal stromal cell
senescence will reduce the functional competitive advantage of Dnmt3a-mutant HSCs and progression to
hematologic pathology. Successful completion of this project will determine the mechanisms by which
hematopoietic-intrinsic and -extrinsic processes confer a competitive advantage to Dnmt3a-mutant HSCs
during aging. We expect that understanding these mechanisms will allow prioritization of targets for
therapeutic intervention to limit CH-associated pathologies including myeloid malignancies, cardiovascular
disease, and type 2 diabetes.

Public health relevance
PROJECT NARRATIVE Aging is a complex process that contributes to reduced function and elevated risk of various diseases in tissues throughout the body, including the blood system. The impact of aging on human health is of increasing societal concern due to the worldwide increase in the age of our population. Our research is relevant to public health because it will provide new information that can be used to develop therapies to sustain a healthy and robust blood system during aging and reduce risk of diseases such as blood cancer, cardiovascular disease, and type 2 diabetes.